Mechanisms underlying spontaneous firing by motoneurons with acute neurotoxicity

Abstract
The toxic effects of platinum-based compounds (PBCs) commonly used in chemotherapy weigh against their
usefulness as the major option for successfully combating lethal cancers. The decision to opt for survival
leaves people worldwide to suffer with PBC neurotoxicity that reduces quality of life by causing neurological
disorders both during and long after treatment. Pain, strange sensations, fatigue, and difficulty with balance
and walking are common symptoms, collectively known as chemotherapy-induced neuropathy (CIN). During
treatment, both sensory and motor neurons are observed to fire unintentionally, i.e. they exhibit spontaneous
firing (SA), and evidence suggests that SA bears responsibility for the earliest signs of distress, including
uncontrolled muscle contraction, cramping, and unusual body sensations. Prolonged impact of SA is
suggested by observations that the intensity of acute signs and symptoms of toxicity is predictive of the
severity of symptoms that develop after with PBC accumulation and persist for months or years after treatment.
This situation describes the urgent need for prevention or treatment of PBC effects on abnormal neuronal
activity and its underlying causes, but no effective solution has been found. The research project proposed
here is designed to meet this need by examining the effects of human-scaled doses of PBC on motor neurons
in cancer-bearing rats studied in vivo. The proposal prioritizes three specific aims as the most logical and
impactful next steps, all supported and proven feasible by preliminary experiments and findings. Aim 1 will test
whether PBC accumulation in motor neuron cell bodies within the central nervous system (CNS) is necessary
or sufficient to induce SA. Emphasis on the CNS is a new direction in the field that breaks with common, yet
untested consensus that SA originates at unusual, i.e. ectopic sites of firing out in the peripheral nervous
system. This new direction is driven by recent and conclusive findings presented here that SA in motor
neurons is produced within the CNS. A possible cause of SA will be tested using methods to measure and
manipulate PBC accumulation in motoneurons. Aim 2 will take advantage of the exceptional access of spinal
motor neurons for studying, within a living animal, the biophysical mechanisms underlying changes in neuronal
excitability and SA. The results will provide the first ever detail about the effects of PBC on intrinsic excitability
of motor neurons and will guide understanding of effects that are entirely unknown for other neurons in the
CNS. Aim 3 will test the possibility that SA in motor neurons is driven synaptically by SA shown here for
sensory neurons. This systematic examination of SA induced by PBC neurotoxicity will significantly advance
the field by critically assessing three major candidate mechanisms having strong potential for evidence-based
impact on urgently needed development of preventative measures or treatments.

Public health relevance
Neurotoxic damage to the nervous system weighs heavily in patients’ decision to use chemotherapy for its life-saving benefits in treating cancer. The toxic effects of the most commonly used and successful chemotherapies significantly reduce quality of life by causing neurological disorders both during and long after treatment, causing pain, strange sensations, fatigue, and difficulty with balance and walking. Building on our recent discoveries, the preclinical studies we propose take a new direction that has the promising potential to identify novel targets for treating neurotoxic damage the neurons ultimately responsible for movement disorders.